Upstate KIDS Follow-Up Study

The Upstate KIDS Follow-Up study began contacting all participants in October 2015 for continuing the study in the this new follow-up phase. A data coordinating center (DCC) developed a new website for online data collection and data management. Ongoing clinic visits will be offered through Fall 2019. At clinic visits participants continues to have extensive measurements made of anthropometry, body fact by bioelectrical impedance, lung inflammation, blood pressure, arterial stiffness by pulse wave velocity and collection of urine, blood and saliva. Data collection will close November 2019.